Vaccine and Treatment Evaluation Units

Project Summary/Abstract
The currently NIAID-funded Vaccine and Treatment Evaluation Unit (VTEU) based at Emory University is
ideally positioned to implement the mission of
the Infectious Diseases Clinical Research Consortium (IDCRC)
.
The Emory VTEU is supported by Emory's rich scientific milieu with numerous synergistic grants and various
thematic research centers covering all IDCRC scientific priority areas. The Emory VTEU infrastructure relies on
two clinical research sites with a total of 16,000 square feet of clinical, laboratory, and pharmacy space and 83
faculty members and staff. Over the past decade as a funded VTEU, we have conducted 51 VTEU protocols,
served as lead on 25 trials, performed endpoint assays for 17 studies, and published 22 high impact papers.
We have enrolled ~3,000 participants, 55% are female and 37% from diverse racial and ethnic backgrounds
with a retention rate of ~93%. With its flexible infrastructure, the Emory VTEU demonstrated surge capacity to
contribute to pandemic influenza, Zika, Ebola, and biodefense efforts by prioritizing resources in funds and
staffing. The Emory VTEU will build on the current surge capacity by strengthening our partnership with the
Georgia Clinical and Translational Science Alliance and collaborating with well-established Emory international
partners on a protocol-specific basis. Additionally, to date, our VTEU has trained 28 fellows and junior faculty.
We will build on our significant record of accomplishment and advance the IDCRC mission by implementing
the following specific aims:
1. Engage a broad range of Emory scientists with expertise in established and newly emerging infectious
diseases in the core science of the IDCRC including concept generation and protocol development.
2. Leverage our access to a unique and diverse population and state-of-the-art research infrastructure to
implement all components of the IDCRC science, including study conduct, data quality control and
assurance procedures, data management, and good clinical, laboratory, and pharmacy practices.
3. Optimize our operational flexibility to further enhance our ability to provide surge capacity to address
emerging infectious diseases and pandemic response.
4. Expand our mentoring capacity and enhance career development opportunities for early stage
investigators in the areas of vaccinology, infectious diseases diagnostics, therapeutics, and prevention.

Public health relevance
Project Narrative The Emory Vaccine and Treatment Evaluation Unit (VTEU) is well positioned to contribute to the mission of the Infectious Diseases Clinical Research Consortium (IDCRC) by conducting clinical protocols for evaluating vaccines, biologics, therapeutics, diagnostics including prognostic and predictive markers, and devices for the treatment and prevention of infectious diseases. The Emory VTEU benefits from the vibrant scientific environment present at Emory University with synergistic grants and thematic research centers, including the Emory Vaccine Center, as well as from the generous support of the institution. This highly supportive infrastructure enhances our ability to address NIAID priority areas including the need for broad scientific expertise, established clinical research infrastructure, flexible operational structure that has substantial surge capacity, access to unique and diverse study populations, state-of-the-art immunology and diagnostics laboratory, a record of accomplishment in designing and completing various complex clinical trials, a commitment to research mentoring, and dedication to training the next generation of investigators.